CORE--CLINICAL

This is a clinical support core. The Aims are: Aim 1. To provide basic administrative support for the operation of the entire Project. Aim 2: To provide basic statistical support for all of the Projects. Aim 3. To screen subjects for the clinical and brain bank components of the Program Project. Aim 4. To recruit subjects for clinical projects. Aim 5. To provide technical and interpretive support for tests and procedures that are preformed in Projects #1 and #2. Aim 6: To provide clinical and research database management.